Development of a Rabbit Model for Myeloperoxidase Deficiency

ABSTRACT
Myeloperoxidase (MPO) is a unique peroxidase, predominantly expressed in neutrophils and stored in their
azurophilic granules, and accounts for ~5% of the total cell protein. Among all the discovered peroxidases,
MPO is the only one that catalyzes two-electron oxidation of chloride anion to produce hypochlorous acid
(HOCl) in the presence of H2O2 derived from the NADPH oxidase. Clinical validation of the importance of the
oxidant-dependent system for optimal host defense rests in part on the severe and often fatal infections seen
in patients with chronic granulomatous disease (CGD), an inherited disorder with non-functional phagocyte
NADPH oxidase. Intriguingly, individuals with inherited MPO deficiency develop a narrow set of infections,
largely by fungi. The molecular basis for such a phenotype of MPO deficiency is not clearly known, but likely
reflects actions by uncharacterized antimicrobial activities that may lie in reserve but are recruited under
severe stress. Clinical data further suggest that MPO contributes to tissue damage and inflammation, and is
involved in the pathogenesis of many inflammatory diseases including cardiovascular diseases, kidney
diseases, pulmonary inflammation, rheumatoid arthritis, skin inflammation, and neuronal diseases. In spite of
the long-observed clinical association between MPO and inflammation, the exact role of MPO in the onset and
progression of inflammatory diseases remains largely elusive. One of the major obstacles impeding progress in
understanding the contribution of MPO to host defense and to inflammation biology is the lack of a faithful
animal model. Widely used in the field, MPO-knockout (MPO-KO) mice fail in many settings to recapitulate
MPO-associated human diseases, as data obtained often contradict those seen in humans. To meet the urgent
need for an accurate faithful animal model, we have produced an MPO-KO rabbit model using CRIPSR/Cas9
gene editing technology. Due to many similarities between the rabbit and human immune systems, we expect
this novel model to be of great value in studying clinical MPO deficiency. Our overarching hypothesis is that
rabbit MPO deficiency replicates human MPO deficiency in both infection and inflammation diseases, providing
a valuable tool for novel basic discovery and therapeutic development. There are two specific aims in this R21
proposal: 1) to determine if rabbit MPO deficiency reproduces human MPO deficiency in infection; 2) to
discover if rabbit MPO deficiency recapitulates human MPO deficiency in inflammation. Completion of this
research will establish a larger animal model for human MPO deficiency for basic research and therapeutic
development, which is expected to greatly advance our understanding of the biology of MPO and the MPO-
related diseases, and to facilitate the search for effective interventions for these conditions.

Public health relevance
PROJECT NARRATIVE Myeloperoxidase (MPO), which gives the distinctive green tinge in pus and phlegm, is the key enzyme that generates chlorine bleach in white blood cells for bacterial killing, and patients lacking this enzyme often contract fungal infection and develop inflammatory diseases. Because the existing MPO-deficient mouse model fails to reproduce the human disease, an accurate and faithful animal model is critically needed. The current application has laid out a comprehensive plan to characterize a novel MPO-deficient rabbit model to meet the need for basic research of MPO-related infection and inflammatory diseases.